Role of structural dynamics in RNA regulation

Project Summary
Messenger RNAs (mRNAs) encode complex regulatory instructions in their 3' untranslated
regions (3'UTRs) that prescribe context-dependent control of translation and decay. Disruption
of mRNA post-transcriptional regulation by mutational lesions or shortening of 3'UTRs has been
linked to diverse human diseases. RNA molecules fold back on themselves into base-paired
secondary structures and occasionally higher-order tertiary structures, and sequence-encoded
structures are hypothesized to play key roles in directing 3'UTR regulation. For example, RNA
structures can provide specific binding sites for RNA binding proteins and may tune the
accessibility of microRNA target sites. RNA structures may also function as molecular switches,
with protein or microRNA binding triggering specific 3'UTR structural changes that alter the
activity of distal regulatory sites. However, little remains known about 3'UTR structures and their
role in post-transcriptional regulation. Existing data indicate that 3'UTRs have heterogenous and
dynamic structures, which makes them challenging to study by traditional chemical probing or
biophysical methods. My research group has recently developed a new single-molecule
chemical probing technology (DANCE-MaP) that makes it possible to accurately define RNA
structural ensembles consisting of 2-3 coexisting states in living cells. We will pursue two areas
of research that exploit and build on the DANCE-MaP technology: (1) We will apply DANCE-
MaP to define 3'UTR folding landscapes and mechanisms of combinatorial regulation by RNA
binding proteins and microRNAs. (2) We will develop next-generation technologies that can
resolve structurally heterogenous RNAs with greater resolution and provide model-free, physical
interpretation of chemical probing data. This work will provide an improved understanding of
mRNA regulatory mechanisms, helping advance efforts to therapeutically target 3'UTRs to
modulate gene expression, and contribute new structure determination technologies that will be
of broad utility to the RNA biology field.

Public health relevance
Project Narrative Messenger RNAs (mRNAs) encode specific regulatory instructions in their untranslated regions (UTRs) that govern when, where, and how much protein should be made from each mRNA. Our studies will investigate how mRNA UTR sequences fold into specific structures, and how these structures impact mRNA regulation. Our results will provide insights into how mutations in UTRs contribute to disease, help improve our ability to design molecular therapies that target UTRs to control gene expression, and facilitate efforts to design synthetic mRNAs as medicines.